Administrative Core

UNIT 5. ADMINISTRATION Unit 5 provides leadership for the Burnham Center, and ensures coordination with other components of MLPCN. Dr. John Reed heads Unit 5, with Dr. Kristiina Vuori as co-Director. This leadership team was highly successful in the MLSCN Phase, and has impressive administrative skills, including direct experience in operating large collaborative research projects. Daily work-flow of the Center is coordinated by the Project Manager, Dr. Thomas Chung. Dr. Shakeela Dad functions as a full-time Outreach Coordinator for the Center.